Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
This proposed P01 program has the goal of creating a locus of research examining the pathways by which
technology and digital media (TDM) exposure and usage impact developmental trajectories and health outcomes
in adolescence. The Administrative Core (Admin Core) of this proposal will provide the necessary support to the
program investigators, staff and collaborators over the longitudinal design of the proposed Projects. This Core
will serve as the common channel through which all scientific, administrative and fiscal communication occur to
facilitate the exchange of information between Project investigators and staff internally, as well as disseminating
the findings of the Projects and communicating research advances to the public. The Admin Core will thus
provide coordination and an organizational backbone for the 3 Projects and 2 Cores involved in this P01
proposal. The Admin Core of this P01 program proposal will focus on five Specific Aims. First, this Core will
provide grant coordination, organization and management services. Second, the Admin Core will organize and
coordinate biostatistical support for Projects 1 and 3. Investigators will also identify novel analysis ideas based
on early findings towards triangulating data across all 3 Projects given the shared participant pool. Third, the
Admin Core will ensure ongoing involvement of this P01 proposal’s team of co-investigators, consultants, and
the internal and external advisory committees. Given that the three PIs are all located at the University of
Wisconsin-Madison, this Program proposal includes an Internal Advisory Committee spanning diverse
disciplines across areas of technology and digital media, as well as adolescent health and development. This
P01 proposal includes strong institutional support including matching funds from the involved departments and
schools, and main campus at UW Madison. Fourth, as a university-based research team, all Program
investigators are committed to the ongoing growth of the next generation of researchers. Thus, a specific aim of
this Core will focus on engaging diverse undergraduate and graduate students in all 3 Projects. Finally, the fifth
aim will focus on ensuring timely and targeted dissemination across local, national and scientific and community
audiences. This Admin Core team includes Core Lead and P01 PI Dr. Megan Moreno, the biostatistical team
includes Dr. Jens Eickhoff whom Dr. Moreno has worked with across several previous projects, the Admin Core
administrative and research staff who all have experience and existing collaborations with Dr. Moreno, and
Communication Lead staff member Ms. Bushman who will ensure that our learnings and findings reach
communities to optimize the impact of this collaborative interdisciplinary research program.

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE CORE Not applicable. Per the Funding Opportunity Announcement PA-HD-22-009, the Project Narrative is not required for the Project or Core components.